Atherogenic mechanisms of SVEP1, a Novel Human Coronary Artery Disease Locus

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease is the leading cause of mortality in the world. It is critical to develop non-lipid
therapies to address cardiovascular disease since significant risk remains after successful lipid reduction. By
using human disease findings as a starting point for experimental investigation, we can focus our resources on
the mechanisms, pathways and therapeutic strategies that are the most applicable to human disease.
The Stitziel Lab discovered a variant in the extracellular matrix gene, SVEP1, that positively associates
with coronary artery disease. To test if SVEP1 is the causal gene in the risk locus, the lab first generated
athero-prone mice that were haploinsufficient for Svep1. These mice were found to exhibit less atherosclerotic
plaque burden than controls. Similarly, conditional deletion of Svep1 in mature vascular smooth muscle cells
(VSMCs) of mice resulted in dramatically less plaque burden. There is a growing body of evidence that VSMCs
play a central role in atherosclerosis, including several disease loci now linked to these cells. In addition to
producing SVEP1, VSMCs contain Notch and integrin receptors that we hypothesize bind to SVEP1. I
discovered that VSMCs grown on recombinant SVEP1 have increased Notch and integrin signaling, as well as
increased transcription of genes involved in cell proliferation and differentiation. SVEP1 induces robust
proliferation of primary VSMCs, which is dependent on both Notch and integrin α9β1 signaling. These
preliminary findings confirm the contribution of SVEP1 to atherosclerosis, potentially by influencing VSMC
proliferation and differentiation in a cell-autonomous manner. Despite these promising leads, the mechanisms
by which SVEP1 and its variants contribute to disease have yet to be fully characterized.
This project will answer critical, outstanding questions about the molecular and cellular mechanisms by
which SVEP1 promotes atherogenesis. I will use complementary molecular techniques, cell culture models and
animal models to address these questions. I first aim to determine if SVEP1 binds directly to Notch and integrin
receptors and, if so, which regions of the protein contribute to binding affinity. This experiment will also clarify
the contribution of each signaling pathway to the overall effects of SVEP1 on VSMCs. The leading risk variant
will be included in these studies, since the variant residue is within the putative integrin binding domain of
SVEP1. I will then interrogate the cellular mechanisms of SVEP1 in atherogenesis using a murine disease
model. This will include performing lineage tracing and single cell RNA sequencing with and without the
endogenous production of SVEP1 by neointimal VSMCs. This in vivo approach complements the proposed
molecular techniques by focusing on mechanisms in their pathophysiologic context. Successful completion of
these aims will reveal the mechanisms by which the common and risk allele of SVEP1 promote atherosclerosis
while providing insight into the pathogenesis of the world’s deadliest disease with potential to reveal new
therapeutic candidates.

Public health relevance
PROJECT NARRATIVE The Stitziel Lab recently discovered a variant in SVEP1, an extracellular matrix protein, that associates with increased risk of coronary artery disease in humans without affecting serum lipids. Our Svep1 knockout murine disease models suggest that SVEP1 is proatherogenic, yet the mechanisms behind its role in disease require further exploration. The goals of this project are to gain mechanistic insight into the molecular and cellular mechanisms by which SVEP1 promotes atherosclerosis in order to improve our understanding of disease pathogenesis, build a foundation of knowledge to explore how variants in SVEP1 influence disease risk, and evaluate the therapeutic potential of targeting SVEP1 as a treatment for coronary artery disease.